RANDOMIZED TRIAL OF PROPHYLACTIC ENDOSCOPIC VARICEAL LIGATION VS. PROPRANOLOL

The specific aims of this study is to compare the relative outcomes of the two treatments, evaluate patient satisfaction with their care, and compare the direct and indirect health care costs of the two treatments. The results of the study will be used to support a grant application to the NIH for the larger, multi-center clinical trial which evaluates the long-term risks and benefits of prophylactive endoscopic variceal ligation compared to nadalol for preventing initial hemorrahage from esophageal varices.